Medications for Alcohol Use Disorder: Unfilled Prescriptions and Treatment Trajectories

PROJECT SUMMARY: Many individuals with alcohol use disorder (AUD) receive no treatment, including
evidence-based pharmacotherapies. Previous research on AUD medication use has primarily relied on claims
data, and thus focuses on only a portion of the AUD medication treatment process (i.e., filled prescriptions).
Using only claims data, it is not possible to distinguish the characteristics of individuals who do not receive a
prescription from a clinician from those who receive one but do not fill it. It is also not possible to understand
how medication prescriptions and fills fit into the trajectory of AUD treatment received. To design practice and
policy interventions that will improve AUD medication use, clinicians and policy makers need to understand
who “falls off” at each point in the treatment process. We propose to use a dataset from a large national
insurer with linked claims and electronic health record (EHR) data for the period 2010-2023, as well as
interviews of AUD providers, in a mixed methods study. The linked data will allow us to observe written
prescriptions for each patient as well as whether or not the prescriptions were filled. The linked data will also
allow us to incorporate clinically relevant information available in EHRs but not claims. Using these data, we
will: 1) For individuals diagnosed with AUD, identify patient and provider characteristics associated with being
prescribed an AUD medication and the time from index AUD encounter to prescription; 2) For individuals
diagnosed with AUD who are prescribed an AUD medication, identify patient and prescriber characteristics
associated with filling the prescription and with time to prescription fill; and 3) Identify trajectories of AUD care
that incorporate information on prescriptions written for individuals diagnosed with AUD, and examine the
association between different treatment trajectories and indicators of subsequent relapse and injury. The
study's mixed methods approach, including semi-structured interviews of providers who treat AUD about the
factors that influence their AUD medication prescribing decisions, will allow a more nuanced examination of
AUD medication prescribing than quantitative analyses alone allow. The findings will help pinpoint where in the
treatment process different types of people fall out of treatment and how different treatment trajectories are
associated with relapse and injury, informing future intervention and policy design.

Public health relevance
PROJECT NARRATIVE: Many individuals with alcohol use disorder (AUD) receive no treatment, including evidence-based medications. Prior studies of AUD medication use primarily relied on claims data and so could not account for whether someone received a prescription in the first place. This study, using linked electronic health record data on medication orders and claims data (combined with qualitative methods), will allow more precise identification of where individuals fall off the path of AUD medication use, and the outcomes associated with different treatment trajectories.